Translational Multimodal Strategy for Peri-Implant Disease Prevention

Dental implants have become an important routine component of dental practice with over five million fixtures
placed annually in the United States and this number is expected to increase significantly in the future. The
peri-implant soft tissue interface is less effective than natural teeth in resisting bacterial invasion, enhancing
vulnerability to subsequent peri-implant disease. Peri-implant diseases are inflammatory conditions affecting
the soft/hard tissues surrounding a functional dental implant. Plenty of experimental evidence indicates that the
accumulation of dental plaque at the soft tissue-implant interface and the subsequent local inflammatory
response seems to be key in the pathogenesis of peri-implant mucositis. Furthermore, in certain individuals, it
will progress to peri-implantitis, resulting in alveolar bone loss and implant failure. The goal of this application is
to create a novel dental implant construct that renders the implant-supported restoration antibiofilm while
providing a tight gingival tissue-implant seal that serves as a barrier to bacterial invasion. This smart dental
implant system is a battery-less system that converts biomechanical forces from human oral motions (e.g.,
chewing or tooth-brushing) into electrical energy and powers light-emitting diodes that enable in situ
phototherapy. When used in combination with a long-lasting antibiofilm restorative surface, this self-powered
precision phototherapy system circumvents problems with the use of conventional antimicrobials. Ongoing
studies indicate that red and near-infrared light is effective in maintaining human gingival tissue cell viability in
the face of mono- and multi-microbial challenges. Furthermore, the antibiofilm restorative surface almost
completely inhibits bacterial colonization. Based on these exciting supporting data, we hypothesize that force-
powering of piezoelectric crystals to produce red and near-infrared light combined with bacterial anti-adhesive
restorations creates an anti-inflammatory, pro-healing environment that provides a robust soft-tissue seal and
prevents the development of peri-implantitis. We anticipate that the creation of this next-generation anti-
inflammatory, antibiofilm dental implant system would increase functionality and provide a new strategy to
prevent and control peri-implant diseases, especially in populations at risk, and reduce the risk of implant
failure.

Public health relevance
PROJECT NARRATIVE Osseointegrated dental implants have become a clinical standard for replacing missing teeth and are now an important routine component of dental practice. Due to its popularity, the presence of implant complications is rising, making it challenging to sustain implants in the long term. We propose to develop an innovative anti- bacterial adhesion and anti-inflammatory dental implant system that prevents implant failure while promoting long-term stability.